Administrative Core

The administrative core at The University of Chicago will provide the projects comprising the program consortium on-going administrative support. It will also provide travel support for the annual meetings of the project leaders and key personnel plus travel support for the program's annual meeting invited speaker/external advisor.